Laser Capture Microdissection System

DESCRIPTION (provided by applicant): A group of investigators at the Oregon National Primate Research Center (ONPRC) request funds to purchase a Laser Capture Microdissection System. The instrument will be used to procure pure populations of cells out of complex tissues, necessary to isolate RNA and proteins for gene expression analyses. Projects participating are making important contributions to understanding development, puberty and aging, to treating metabolic diseases, obesity and diabetes, depression, alcoholism, vascular disease, infant respiratory deficiencies, to finding new contraceptive methods. After a careful market evaluation, ArcturusXT was selected as the most versatile system, capable to meet the very diverse needs of the participating users. The new instrument will be placed in the ONPRC's Imaging and Morphology Core and will thus take advantage of the expertise and organization of a well established and supported core. ONPRC commits to ensuring long term efficient use of the instrument by covering the costs of space remodeling, service contract and personnel salary. Any instrument time not used by the projects presented here will be available to other scientists at Oregon Health &Science University, the host university, as well as to the many national and international collaborators that ONPRC traditionally hosts, thereby extending the overall benefits.